New Mexico IDeA Networks of Biomedical Research Excellence (INBRE)

PROJECT SUMMARY
This project is a continuation of the New Mexico Idea Network of Biomedical Research Excellence (NM-
INBRE), a statewide network that promotes biomedical and community-based research and training through
scientific research in the following thematic areas: structure and function of biomolecules, cell and organism,
pathogens, and population and community health. The network includes nine institutions of higher education,
two Tribal Communities, and an innovative Sequencing and Bioinformatics Core. The program provides
research, training, and career opportunities to early career faculty and students, many from underserved
populations. NM-INBRE's effective organizational structure and institutional cooperation with recognition of
each partner's important and unique roles builds upon its scientific achievements, effective integration of
training and research using bioinformatics and next-generation sequencing technologies, connect new
investigators with established mentors and collaborators, and contribute to developing New Mexico's
biomedical research workforce. The specific aims are: 1. To build on the established multi-disciplinary research
network with a scientific focus to strengthen the lead and partner institutions' biomedical research expertise
and infrastructure, 2. To build and increase the research base and capacity of New Mexico by providing support
to participating faculty, postdoctoral fellows, and graduate students, 3. To provide research opportunities for
students from primarily undergraduate institutions, community colleges, and minority-serving institutions to
build a pipeline to health-research careers within IDeA states, 4. To enhance the science and technology
knowledge of the New Mexico's workforce, and 5. To promote research and training collaboration through
participation in a regional alliance of INBRE Networks (RAIN) in the Western Region. Organizations
participating in NM-INBRE include New Mexico State University (NMSU) as the lead institution, with research-
oriented research-intensive doctoral-degree-granting programs at New Mexico State University and at both the
University of New Mexico (UNM) main campus and its Health Sciences Center (HSC). Scientific partner
institutions include Eastern New Mexico University (ENMU), New Mexico Institute of Mining and Technology
(NMT), New Mexico Highlands University (NMHU), Western New Mexico University (WNMU), Northern New
Mexico College (NNMC), San Juan College (SJC), the National Center for Genome Resources (NCGR), and
the Pueblos of Acoma and of Zuni.

Public health relevance
Project Narrative: The NM-INBRE program provides research, training, and career development opportunities for early-career faculty and students at all levels of education. We deliver innovative biomedical research that contributes to improving human health, especially to underserved populations in New Mexico.